USE OF BODY FAT AND PROTEIN STORES DURING FASTING AND REFEEDING

To do a comparative study of fuel utilization after a 60 hour fast in young and old subjects, using stable isotope tracer infusions. To determine whather protein and fat stores are replenished at different rates during refeeding in the young and old.